Medical Scientist Training Program

The overall mission of the Medical Scientist (MD-PhD) Training Program (MSTP) at the University of Alabama at Birmingham (UAB) is to train the next generation of physician-scientists who do rigorous translational research in academic or industry settings and who promote safety and rigor in their careers. Although the ultimate career pathway for individual trainees extends a broad spectrum from the conduct of basic biomedical research to clinical trials of novel therapeutic agents or procedures, the net effect of this cadre of investigators will be to increase the translation of basic biomedical understanding into clinical practice. Our Program focuses on the following objectives: 1) training students to master clinical knowledge and skills of medicine; 2) training students to master knowledge of a scientific discipline, including training in quantitative methods; 3) promoting the development of rigorous experimental and critical thinking skills; 4) promoting responsible conduct of research and ethical behavior; 5) training students in communication skills in science and medicine; 6) promoting supportive mentorship; 7) training students in leadership skills; 8) promoting resilience, wellness, and professional development; and 9) developing graduates who continue in the physician-scientist workforce.
The UAB MSTP curriculum has three distinct phases: two years of basic science course work and summer research rotations (Preclinical Phase), an extended research period culminating in the PhD degree (Research Phase), and final clinical training leading to the MD degree (Clinical Phase). Each year, our MSTP will matriculate 12 students into the first program year and accept another one or two students through Advanced Transfer pathways (the NIH MD-PhD Partnership Training Program pathways, and MD or PhD to MSTP Advanced Transfer pathways). Our program currently has 82 students. Unique aspects and strengths of the UAB MSTP include high numbers of funded NRSA awards, 97% program completion rate, a lower (7.7 year) time to degree average than the national average, 100% residency match rate for MSTP graduates, exceptional faculty mentors across a broad array of specialties, options for research in non-traditional research programs, vertical integration of students, extensive student involvement and ownership in the program, strong clinical continuity training during the PhD years, and Advanced Transfer options. Our program will build on these strengths and nurture new ones, including a new alumni mentoring program and a new MSTP-focused learning community. Strong MSTP recruiting, leadership, and institutional support will ensure continued success of the UAB MSTP.

Public health relevance
NARRATIVE The rapid advances in biomedical sciences in the past several decades have resulted in a critical need for well- trained investigators who also have direct involvement with clinical medicine to translate new discoveries in biomedical sciences into workable clinical applications. Medical Scientist Training Programs, such as the one at UAB, which train the most outstanding individuals in both modern medicine and the special intellectual perspective and technical know-how of biomedical science, are a key component for meeting this need.